Evaluating the effects of reproductive health training on provider behavior

PROJECT SUMMARY:
Training of health professionals in sexual health care is critical to address a broad array of a nation’s sexual
and reproductive health concerns. Research evaluating the effects of sexual health curricula on provider
behavior is rare. In sub-Saharan Africa, an environment with the world’s highest rates of HIV, STIs, and
multiple sexual and reproductive health challenges, training of health students in sexual health care is almost
non-existent. Consequently, a rigorous study of its effects is needed if such education is to be widely adopted.
In our “Training for Health Professionals” (THP-1) study, at Muhimbili University of Health and Allied Sciences
(MUHAS) in Tanzania, we conducted formative research to identify the most common sexual health concerns.
We then tailored a sexual health curriculum training for healthcare providers to the African context and
conducted the world’s first single-blind, randomized controlled trial of its effects. Participants were 412 nursing,
midwifery, and medical students at MUHAS. Post-test evaluations with the intervention arm showed the
curriculum to be highly acceptable, culturally appropriate, needed, and feasible. At 3-month follow-up, as
compared to controls, intervention arm students had moderate-to-large increases in sexual health knowledge,
improved attitudes, and improved clinical skills. As required in a renewal application (THP-2), our long-term
objective remains “to improve the sexual health outcomes for individuals in Tanzania by building the sexual
and reproductive healthcare delivery skills of the health workforce.” We have three new specific aims. Aim 1
will assess the medium and long-term effectiveness of an African-centric, sexual health curriculum. We will
conduct a single-blinded RCT of the curriculum against a waitlist control arm, to assess the effects on sexual
health knowledge, attitudes, and counseling skills at 6-, 12- and 24-month follow-up (n=155 students per arm;
310 in total). In Aim 2, we will develop a train-the-trainer curriculum. We will conduct a training needs
assessment of faculty at the ten other health universities in Tanzania, develop training materials, and pilot the
training to faculty at two other health universities: University of Dodoma (UDOM) and Kilimanjaro Christian
Medical College (KCMC). In Aim 3, we will conduct a Phase IV trial. This will be an observational study of the
curriculum being taught by their faculty at the two new sites with 3- 6- and 12-month follow-up. MUHAS,
KCMC, and UDOM are the largest health universities in Tanzania. This curriculum has high potential to be
widely adopted as a new standard of training across Tanzania. These results also have high potential to inform
the adaptation of sexual health curricula across Africa and beyond the continent, to other LMICs.

Public health relevance
Narrative: In Training for Health Professionals (THP-1), we demonstrated that a sexual health curriculum tailored to the challenges in Africa is effective short-term in training students in sexual health. In THP-2, we will study the medium to long-term effects, pilot a program to train faculty to deliver the curriculum, and then study if the curriculum produces the same results in “real world” conditions as it did in the rigorously controlled study. Successful completion of this grant will provide us with the evidence and tools needed to disseminate this intervention across Tanzania, to other parts of Africa, and to other LMICs.